Mesenchymal stromal cells for treatment of radiation-induced xerostomia

PROJECT SUMMARY/ABSTRACT
Radiation-induced xerostomia (RIX) is a condition of subjective dry mouth caused by radiation therapy
to the head and neck and manifested as hyposalivation and altered sialochemistry. RIX is the most common
chronic side effect observed in HNC patients receiving radiation therapy and despite improvements in radiation
delivery remains a critical issue for patients. Currently available treatments provide temporary palliation and in
some cases (e.g. pilocarpine) can be accompanied by side effects that are as bad or worse than xerostomia.
There is a critical need for a treatment that will safely and effectively alleviate RIX without compromising
patient quality of life. A small phase I study suggested that MSC therapy could improve the perception of dry
mouth and salivary gland function in patients with RIX. However, the mechanisms by which MSCs elicit this
effect remain unknown and none of the successful studies investigated to use of cryopreserved MSCs. We aim
to fill this important knowledge gap by identifying an optimal source of MSCs for treatment and understanding
how MSCs improve salivary function to optimize treatment to maximize patient benefit. This proposal intends to
fill this knowledge gap which will potentially lead to the development of novel and effective therapies for RIX.
We hypothesize that MSCs provide a reparative effect to the salivary gland through paracrine signaling.
We will investigate the short-term and long-term functions of MSCs following injection into the submandibular
gland and identify whether there is an ideal potential tissue source for MSCs in terms of cryo-recovery and RIX
treatment. We seek to address three questions critical to understand and treat RIX: 1) identify an ideal tissue
source for MSC to treat RIX; 2) investigate the effects of MSC treatment on the salivary gland in acute and
late-phase radiation damage; and 3) determine if MSC-based products elicit the same effects as MSCs alone.
In Aim 1, we will evaluate the ability of MSCs derived from marrow, adipose, and submandibular gland tissue
to recover after cryopreservation following IFN-ɣ pre-licensing and evaluate the effects of these MSCs on
salivary tissue in vivo and in vitro. We will characterize the secretome of MSCs from different tissue origins
alone and investigate bi-directional effects of salivary gland tissue on this secretome using a salivary organoid
model. Finally, we will confirm in vivo, differences in reparative effects based on MSC source. In Aim 2, we will
define the effects of IFN-ɣ pre-licensed, cryopreserved MSCs in RIX by studying both acute and long-term
effects on saliva production and salivary gland architecture in-vivo. We will also investigate the effects of MSC-
based products like MSC conditioned media and MSC-derived exosomes on salivary function in vivo and in
vitro. Together this work will provide an improved understanding of how MSCs ameliorate radiation damage,
support the development of novel therapeutics for the treatment of RIX, and provide an outstanding training
opportunity for the PI.

Public health relevance
PROJECT NARRATIVE: Radiation induced xerostomia (RIX) is among the most common side effect of radiation observed in head and neck cancer patients, has limited and relatively ineffective treatment options, and can cause severe adverse effects that damage patient’s quality of life. This proposal aims to evaluate the use and efficacy of mesenchymal stromal cells (MSCs) in the treatment of RIX in a mouse model and to support the career development of the PI. Our long-term goal is that this work leads to the development of novel and effective therapies for RIX to improve patient’s quality of life after radiation for head and neck cancer.